N-terminal acylation of Lipoproteins in Firmicutes

Project Summary
The long term goal of the application is to understand why and how bacterial lipoproteins in the medically
important Firmicutes phylum undergo structural modifications. Lipoproteins are membrane associated proteins
tethered to the bacterial surface through an acylated N-terminal cysteine anchor. They are ubiquitous cell
envelope structures in both gram-positive and gram-negative bacteria, playing key roles in nearly every aspect
of bacterial cell envelope physiology. Due to their functional importance, abundance, universal distribution, and
the structurally unique acylated N-terminal cysteine, the innate immune system detects bacteria by binding the
N-terminus of lipoproteins using the Toll-like receptor 2 (TLR2) family. TLR2 activation triggers a pro-
inflammatory cytokine/chemokine response to clear bacteria as well as to orchestrate humoral immunity.
However, there is emerging evidence that acylation patterns in lipoproteins from the Firmicutes phylum are not
canonical TLR2 ligands nor are they static in structure. Firmicutes synthesize lipoprotein chemotypes varying in
acyl chain number, length, and attachment position using an array of accessory lipoprotein biosynthetic genes.
Gene distribution varies at both the genera and species level, and can even differ at the strain level due to
circulating plasmid/transposon encoded lipoprotein remodeling genes. Lipoprotein composition is also
dynamically regulated by the growth environment, including copper which has been shown to induce expression
of certain N-terminal modifying genes. This project aims to uncover the physiological need(s) for distinct
lipoprotein N-terminal modification systems and to characterize the enzymes involved. While select lipoprotein
structural modifications confer TLR2 evading capabilities in host associated bacteria, lipoprotein N-terminal
acylation/acetylation is also found in environmental lineages which suggests a broad selective pressure. Given
copper co-induces both lipoprotein N-terminal modification and copper resistance genes, it has been proposed
that copper directly binds to the free N-terminus and inhibits cell growth unless N-modified. This project will
investigate the impact of N-terminal lipoprotein modifications on copper binding by measuring growth under
copper challenge conditions requiring specific lipoprotein functions, using Tn-seq to compare chemotype-specific
copper sensitization gene networks, and assaying oxidative damage to model lipopeptides isolated from both
actively respiring cells and under in vitro reaction conditions. In the second aim, the recently discovered
lipoprotein N-acylating enzymes LnsAB from Staphylococcus aureus will be reconstituted. Targeted mutations,
acyl chain donor, and possible protein-protein complex formation will be examined using genetic and biochemical
approaches. The final part of the project will examine how N-acetylated lipoproteins are made using genetic
transposon screens and biochemical assays, and what impact lipoprotein acetylation has on key phenotypes.
By understanding lipoprotein synthesis, the project will shed light on the complex interplay between lipoprotein
chemotype, copper exposure, TLR2 recognition, and in turn a critical axis governing host-Firmicutes interactions.

Public health relevance
PROJECT NARRATIVE Bacterial lipoproteins are structures located on the surface of all bacteria that are critical to bacterial fitness and their potential to cause infections. Lipoproteins are detected by components of the immune system responsible for mounting a response to clear the infection. This project aims to understand how bacteria make their lipoproteins and why they change the structure of their lipoproteins, a process that ultimately impacts the ability of immune system to detect and respond to bacteria.